SULFORAPHANE IN HUMAN VOLUNTEERS AFTER INGESTION OF BROCCOLI

This pharmacokinetic study will examine the physiological fate of sulforaphane and its glucosinolate in human subjects after consuming raw or cooked broccoli in a crossover fashion. The levels and metabolism of sulforaphane in raw vs. cooked broccoli will be compared.